Support for Toxicological Data for the National Toxicology Program

The objective of the Support for Toxicological Data contract is for Contractor to provide staff with the ability to apply sound scientific and toxicological principles and an intimate knowledge of NTP toxicological study designs to support the acquisition of data from NTP toxicological studies, the integration of the data across studies and toxicological domains, and the presentation of the data in a meaningful format for use in decision-making by NTP scientists, other government agencies and the public at large. The National Toxicology Program (NTP) is an interagency program headquartered at NIEHS and was established by the Secretary of Health and Human Services to provide information about potentially toxic chemicals to regulatory and research agencies and the public, coordinate toxicology research and testing activities and strengthen the science base in toxicology.